Laboratory Flexible Funding Model- Minnesota Department of Agriculture

PROJECT SUMMARY / ABSTRACT
The Minnesota Department of Agriculture (MDA) Laboratory Services Division (LSD) is seeking funding under
FDA funding opportunity RFA-FD-25-007, “Laboratory Flexible Funding Model (U19)” The MDA laboratory is
applying for the following components: A1: Microbiology Human Food Product Testing, A3: Microbiology
Animal Food Product Testing, A6: Microbiology Food Defense, A7: Microbiology Method Development and
Method Validation, A8: Microbiology Capacity/Capability Development, B1: Chemistry Human Food Product
Testing, B2: Chemistry Animal Food Product Testing, B3: Chemistry Food Defense, B4: Chemistry Method
Development and Method Validation, B5: Chemistry Capability/Capacity Development. Each analytical track
has its own research strategy.
In our cooperative agreement proposal, we establish that the MDA laboratory meets the eligibility requirement
for this funding opportunity. Further, we demonstrate that the MDA laboratory is well-positioned to achieve the
program outcomes outlined in the announcement.
Project Summary/Abstract - Minnesota Department of Agriculture

Public health relevance
PROJECT NARRATIVE The MDA Laboratory Services Division will work with the MDA State Regulatory Program (SRP) and the FDA to enhance the capacity and capabilities of state human and animal food testing laboratories in support of an integrated food safety system. Our work will support the goal to strengthen and improve collaboration of surveillance testing activities between the FDA and state laboratory partners to continue building a nationally integrated laboratory science system. The MDA laboratory will help meet this goal by providing the FDA the data necessary to help identify and address hazards in human and animal food products. Through the sharing of high-quality, defensible laboratory results, early identification and regulatory response to adulterants in food will be promoted. Project Narrative - Minnesota Department of Agriculture